Exosome-Based Pathological Microenvironment-Responsive Nanocapsules for Targeted Heart Repair

PROJECT SUMMARY
The proposed research project addresses the need for a bioengineering approach to a smart and
targeted exosome-based therapeutic delivery platform that can promote tissue repair after myocardial infarction
(MI). Accumulating evidence in both preclinical and clinical settings has consistently indicated the exosomes
secreted from adult stem/stromal cells orchestrate the principal modes of action of cell therapy to repair the
injured heart muscle following MI. Exosome-based therapeutics represent a paradigm shift from conventional
cell-based approaches to cardiovascular therapy. However, current exosome-based therapeutics suffer from
several problems including lack of targetability, complicated fabrication process to load additional therapeutic
cargos, and expense. In addition, technologies that enable controlled delivery of exosome-based products have
yet to be explored. To overcome these challenges, we propose to develop a smart cardiotherapeutic
nanocapsule (CardioXo) for the targeted and controlled delivery of both mesenchymal stem cell-derived
exosomes (MSC-Exo) and therapeutic proteins to promote heart repair post-MI. Our central hypotheses are that
(1) the CardioXo functionalized with both exosomes and cardioprotective proteins (e.g., prokineticin 2, agrin,
insulin-like growth factor 1, myeloid-derived growth factor) can be engineered via an electrostatic layer-by-layer
assembly process combined with a novel enzyme-mediated radical polymerization (EMRP) technology; and (2)
the CardioXo can enable the delivery of combination therapeutics in response to the upregulation of matrix
metalloproteinases (MMPs), a hallmark of cardiac ischemic injury, and trigger the reparative signaling pathways
mediated by therapeutic proteins to repair the ischemic heart. The innovation of the proposed CardioXo strategy
includes (1) targeting to the injured cardiomyocytes; (2) ability to deliver combination therapeutics in an on-
demand fashion by leveraging cardiac pathology in the ischemic heart; (3) dual-regenerative mechanism for
targeted heart repair that combines the exosome-mediated paracrine mechanism similar to stem cell therapy
with the cardioprotective protein-mediated signaling pathways. We will fabricate and optimize the CardioXo
loaded with various cardioprotective proteins and assess the in vitro bioactivity of CardioXo. The safety,
functional benefits, and the potential modes of action of CardioXo therapy will be investigated in rats with
ischemic heart injury. Successful execution of the proposed research project will establish a mild and facile
approach to exosome functionalization and form the foundation of an innovative and off-the-shelf exosome-
based therapy based on smart and targeted nanomedicine for the repair and regeneration of the post-MI heart.
Although this particular grant application targets the heart, the CardioXo strategy represents a platform
technology that can be generalized to the repair and regeneration of multiple tissues.

Public health relevance
PROJECT NARRATIVE Ischemic heart disease remains the leading cause of death in the United States, impacting the lives of millions of Americans each year. This project aims to develop a smart targeted nanocapsule based on naturally- occurring nano-sized vesicles (exosomes) derived from stem cells to recognize and repair the injured heart tissue after a heart attack. This will lead to a novel approach to the treatment of ischemic heart disease.